Disposable Perfusion Phantom for Accurate DCE-MRI Measurement of Pancreatic Cancer Therapy Response

PROJECT SUMMARY / ABSTRACT
The overall goal of this study is to validate a UAB-invented perfusion phantom named P4 (Point-of-care
Portable Perfusion Phantom) for accurate DCE-MRI measurement of pancreatic tumor response to
neoadjuvant therapy. DCE-MRI has been utilized to noninvasively assess early therapeutic response in solid
tumors by detecting changes in tissue perfusion prior to anatomic tumor shrinkage. However, measurement
variability across different scanners remains a major concern in multi-site trials of DCE-MRI. To address this
concern, we invented the P4 that is small enough to be imaged concurrently in the bore of a standard MRI
scanner with a patient, thus can serve as an internal reference to detect and correct the scanner-dependent
variation in quantitating DCE-MRI parameters. We have confirmed that the use of this device decreased
variability in DCE-MRI measurement to about 4%, although it was about 20% before correction. We now
hypothesize that the P4 can help identify early therapeutic response of pancreatic tumors in the neoadjuvant
setting. Pancreatic tumors are typically hypo-perfused, but we have recently demonstrated that the tumor
perfusion can be significantly increased after an effective chemotherapy. Choosing the more effective therapy
early is particularly important for patients with borderline-resectable pancreatic cancer, as an effective therapy
can downstage a tumor to allow curable surgery. Three specific aims are proposed as follows. Aim 1 (UG3-
1): Develop a disposable P4 that is concurrently imaged with a patient for improved accuracy and
reproducibility in quantitative DCE-MRI measurement. For routine and widespread clinical use, the phantom
should be ready-to-use, inexpensive and disposable. Injection molding methodology will be employed to
manufacture the disposable P4. Aim 2 (UG3-2): Develop a software package analyzing abdominal DCE-MRI
images obtained with the P4. Image processing will be conducted sequentially in eight steps. To date, we
have developed eight prototype software program modules (one for each step). In this study, we aim to
combine all eight modules for seamless data flow, while making each module automated/semi-automated not
only to reduce user bias but to improve speed of operation. The software front panel will be updated for more
efficient operation using feedback from multiple users. Aim 3 (UH3-1): Evaluate the changes of DCE-MRI
parameters as surrogate imaging biomarkers for pancreatic cancer therapy response in a multi-site setting
after error correction using the P4. A total of 50 patients with borderline resectable pancreatic cancer entering
neoadjuvant therapy will be recruited in two research institutes (n=25 per institute). The changes of DCE-MRI
parameters in tumors for 4 weeks after therapy initiation will be correlated with the therapeutic response
assessed by margin-negative resection rate after completion of neoadjuvant therapy, and evaluated as
surrogate biomarkers after P4-based error correction.

Public health relevance
PROJECT NARRATIVE The purpose of this project is to validate a UAB-invented perfusion phantom as a clinical tool to measure pancreatic tumor response to therapy early and accurately in dynamic contrast-enhanced magnetic resonance imaging (DCE-MRI). During UG3 phase, a disposable perfusion phantom and a data analysis software package will be developed. During UH3 phase, the clinical utility of those will be validated to improve the accuracy of DCE-MRI measurement for early assessment of pancreatic tumor response to therapy.